South Texas Alzheimer's Disease Center Administrative Core

PROJECT SUMMARY/ABSTRACT – Administrative Core
The South Texas Alzheimer’s Disease Center (STAC) Administrative Core (AC), part of the
collaborative effort of University of Texas Health Science Center at San Antonio (UTHSA) and
the University of Texas Rio Grande Valley (UTRGV), will provide the overarching leadership and
governance for the STAC along with directing new initiatives aimed at training and supporting
innovative research approaches with the goal of reducing health disparities in Alzheimer´s
disease and related disorders (ADRD). The AC will serve as an integral administrative hub for
each Core by acting as the central resource for financial review, human resources
management, contract management, grants management, and data/biospecimen /resources
sharing. The Specific Aims of the AC are: 1) Lead the overall direction of the STAC by holding
continuous strategic planning sessions with national and international experts in AD research; 2)
Review, fund and oversee novel AD developmental projects from across South Texas with input
from the STAC advisory committees and NIA with the goal to provide seed funding to new
investigators that will advance the field and ultimately result in greater funding through other NIH
opportunities, foundations, or philanthropy; 3)Identify and support mentees involved in
transformative AD research, community engagement, and education with the focus of
advancing careers centered around the ADRD research and education; 4) Engage in routine
financial review and analysis of all STAC functions to ensure maximal ROI of existing Cores and
projects as well as to support new initiatives. 5) Serve as the integral administrative hub for
each Core and collaborative site by acting as the central repository for resources such as
contract management, finance, HR, and grants management. Ensure compliance with human
subjects, scientific integrity, data sharing, and fiscal policy requirements of the NIH. 6) Promote
integration of all STAC Cores by holding regular meetings between all Core leaders and
scientific advisory members to discuss strategy and progress of each Core. 7) Recruit and
retain faculty and staff who are underrepresented in neuroscience by fostering an inclusive
environment with the aid; 8) Encourage national, state, and local collaboration through
interaction with other ADC’s, NIH, the data coordinating center, and engage AD clinicians and
scientists at UTHSA/UTRGV and externally; 9) Bolster STAC funding and resources through
actively engaging in philanthropic initiatives and seeking public private partnerships; 10) Ensure
the STAC is promoted as the premier AD resource in South Texas by routinely publicizing
research, community engagement and educational initiatives to the state and local community
with guidance from NIA. The AC will provide an effective and efficient administrative
infrastructure for the STAC to establish, maintain, and grow a robust, interdisciplinary, cross-
institution education and research enterprise that will advance the goal of reducing the burden
of ADRD in our nation, and particularly addressing health disparities for Hispanics with ADRD in
Texas.